Simultaneous Treatment of Viral and Bacterial Otitis Media Using Plant Natural Products

1 Project Summary
2 Otitis media (OM) is a major child health burden. It is the most commonly diagnosed pediatric disease and the
3 #1 reason for antimicrobial prescription to US children. Moreover, 62% of children with OM demonstrate viral
4 infections in their middle ear, to which antibiotics are ineffective but prescribed nonetheless. The widespread use
5 of systemic antibiotics against a disease of such high prevalence and recurrence is believed to breed antibiotic
6 resistance. To treat viral and bacterial infections simultaneously, we will design and synthesize sophisticated
7 plant natural products (PNPs) and their derivatives with no known drug resistance,. The state-of-the-art synthetic
8 biology pipeline that we pioneered will enable the optimization and scalable production of antimicrobial PNPs
9 with enhanced permeability and antimicrobial efficacy. The novel PNP compounds will be delivered locally into
10 the middle ear using a proven hydrogel, which is an easy-to-apply liquid at room temperature and gels quickly
11 and firmly upon contacting warm tympanic membrane (TM). Chemical permeation enhancers inside the gel can
12 overcome the impermeable barrier of the TM and bring the PNPs into the middle ear. We have demonstrated
13 that a single application of the hydrogel formulation provides enough antibiotics for a 7-day treatment, eradicating
14 the infection in a chinchilla OM model.
15 The current application attempts to completely eliminate antibiotic usage in this prevalent childhood disease and
16 to mitigate OM-related drug resistance by using a stand-alone therapy that treats both bacterial and viral
17 infections. It focuses on the production and modification of berberine, an alkaloid derived from medicinal plants.
18 Berberine has demonstrated antimicrobial effects against Gram-positive and -negative bacteria including MRSA
19 and has shown antiviral properties against multiple viruses. This work will leverage our experience in PNP
20 biosynthesis to reconstruct a biosynthetic pathway in yeast for berberine production. We will incorporate diverse
21 tailoring enzymes (e.g., halogenases) and modified precursor molecules to produce modified berberine
22 derivatives that are difficult to achieve by conventional chemical synthesis. The therapeutic efficacy and
23 biocompatibility of the modified berberine derivatives will be tested using an established chinchilla OM model.
24 The knowledge and techniques developed in this project will provide new insight into overcoming the biological
25 barriers in the ear via molecular design and new treatments for acute and recurrent OM. The focus on berberine
26 is based on its known antimicrobial effect, and the general methodologies are applicable to other PNPs that
27 could treat ear diseases beyond OM.

Public health relevance
Project Narrative The project aims to achieve better treatment outcomes for otitis media, an extremely common pediatric disease, and to mitigate the development of antibiotic resistant bacteria. The therapeutic systems developed in this project will enable the simultaneous treatment of viral and bacterial otitis media by designing novel antimicrobial plant natural product derivatives using synthetic biology techniques. The fundamental investigations on tympanic membrane permeability, the effects of plant natural products on OM cure rate and nasopharyngeal microbiome will advance our understanding of acute and recurrent otitis media, and the technological development in overcoming biological barriers in the ear.